Automated, Assistive, Non-Contact Sleep Quality Monitor for Individuals with Alzheimer Disease

Project Summary/Abstract
Proposed is a sleep monitoring system specifically designed for care providers of persons with Alzheimer’s
disease and Alzheimer’s Disease Related Dementias (AD/ADRD) to monitor sleep disturbances and trends.
Significance: Studies indicate that approximately 1 in 3 patients with AD/ADRD suffer from sleep and other
nighttime disturbances such as insomnia and disruption of sleep, wandering, day/night confusion, repeatedly
leaving bed, nightmares, and hallucinations. Sleep disturbances often lead to reduced health and lower quality
of life for persons with AD/ADRD and in Long Term Care (LTC) settings place burden on staff. Nearly half of all
people in LTC settings have a diagnosis of AD/ADRD. Unfortunately, clinical providers and staff in LTCs are
limited in their ability to identify and treat these conditions as current methods of sleep quality assessment are
either inaccurate, time consuming, or inappropriate for use with those who have AD/ADRD. Hypothesis: We
hypothesize that a system which allows for practical, long-term monitoring of sleep quality metrics for patients
with AD/ADRD will lead to greater documentation of sleep problems, greater prescribing of appropriate
nonpharmacological treatment, and improvements in sleep quality and daytime inactivity. Specific Aims: To
transition the Phase I prototype to a production ready product and evaluate the efficacy of the system in Phase
II IDL will 1) Create production-ready system with updated hardware, firmware, and mechanical design 2)
Create cloud-enabled backend, implement web / mobile interfaces, and refine sleep metrics and 3) Evaluate
system’s real-world feasibility, acceptability, and utility in a before-after clinical trial.

Public health relevance
Project Narrative A review of sleep disturbance prevalence among persons with dementia reported that on average 1 in 3 residents suffer nighttime disturbances such as insomnia and disruption of sleep, wandering, day/night confusion, repeatedly leaving bed, nightmares, and hallucinations. These disturbances often lead to reduced health and lower quality of life for persons with AD/ADRD while causing tremendous stress among long-term care staff. A practical system capable of monitoring sleep quality in individuals with AD/ADRD in long-term care would allow staff and clinicians to better detect, document, tailor treatments, and monitor sleep, towards improved quality of care and quality of life.